Sialoglycoproteomic network and target discovery for Alzheimer's disease

Project Summary / Abstract
Alzheimer's disease (AD) is a devastating dementia with no effective treatment, underscoring the critical
need for better understanding the pathogenic mechanisms of this disease and uncovering new molecular
vulnerabilities to target for therapy. This project addresses an important yet under-studied area of AD
research and aims to discover sialylation-mediated disease processes and novel targets for early diagnosis
and intervention. Protein sialylation is a post-translational modification that covalently attaches sialic acids
(negatively charged nine-carbon monosaccharides also known as neuraminic acids) onto glycoproteins to
generate sialoglycoproteins. Accumulating evidence indicates that sialic acids on sialoglycoproteins not only
affect protein conformation, activity, and trafficking, but also serve as regulators of molecular and cellular
interactions, acting as a biological mask for blocking molecular recognition and/or as a biological recognition
signal for mediating interactions with specific proteins such as Siglecs (sialic-acid-binding immunoglobulin-
type lectins). Protein sialylation is vital to brain function and homeostasis, as highlighted by the fact that
genetic mutations in enzymes for catalyzing sialylation, desialylation, or sialic acid metabolism cause human
diseases with brain dysfunction and neurological abnormalities. Furthermore, GWAS studies have identified
Siglec-3 (also known as CD33) as a risk factor for AD, underlining the connection between dysregulated
sialylation-mediated signaling and AD pathogenesis. However, very little is currently known about human
brain sialoglycoproteome and its alterations in AD. The proposed project will address this knowledge gap
and use an innovative, multi-faceted approach that combines sialoglycoproteomics, network biology, cell
biology with translational research in human patient specimens to discover and study sialoglycoproteomic
networks and sialylation-based molecular mechanisms and pathways underlying brain function in health and
Alzheimer's disease. Furthermore, this project will perform large-scale high-resolution analyses of
sialoglycoproteome changes in human AD and control cerebrospinal fluid, and blood serum samples to
identify novel biomarkers for early diagnosis and monitoring disease progression. Findings from the proposed
research will advance our understanding of AD pathogenesis and provide novel targets for AD diagnostic
and therapeutic development.

Public health relevance
Project Narrative The enormous societal burden of Alzheimer's disease (AD) and lack of effective means of prevention and treatment emphasize the importance of better understanding AD pathogenesis to find new targets of intervention. This project will perform innovative research to discover AD-specific sialoglycoproteome changes and identify novel biomarkers and targets for improving AD diagnosis and treatment.